Activities of nucleoprotein complexes visualized in single-molecule experiments

Project Summary
Mechanistic understanding of living things requires our understanding of how proteins and DNA interact
together to generate functional chromosomes. This understanding is central to preserving human health,
dealing with genetic disorders, and fighting pathogenic organisms. The proposed projects are focused on
single-molecule analyses which permit direct visualization of biomolecule interactions, and can be used to
analyze protein-DNA interactions in detail. The aims of the proposal include careful study of a facilitated
dissociation "exchange" mechanism for removal of proteins from DNA that suggests a major revision of
conventional descriptions of protein turnover on DNA, and which will affect a wide range of studies of gene
regulatory and chromosome structural proteins. The second and third aims are focused on study of
mechanisms of large "Structural Maintenance of Chromosomes" (SMC) protein complexes which mediate the
folding of chromosomes in eukaryote cells. The second aim concerns understanding the mechanics of
compaction and DNA substrate selection by the Smc5/6 complex, which plays a key role in separating
replicated chromosomes from one another during cell division, while the third aim concerns direct microscopy
observation of the mechanism by which Smc5/6 compacts DNA. The second and third aim will also include
side-by-side comparisons of Smc5/6 and the more well-understood condensin complex. The highly
mechanistic analyses of DNA processing machinery that are proposed will give us a stronger understanding of
how cells interpret, fold and change their genomes, leading to a better understanding of pathologies where
those functions are impaired, and better understanding of how to target those functions in pathogenic
organisms.

Public health relevance
Narrative All genetic processes are ultimately controlled by protein-DNA interactions. Incorrect processing of DNA in humans lead to a wide range of genetic disorders, while induction of changes in DNA processing provides a strategy to control pathogenic organisms. The proposed project seeks to obtain mechanistic understanding of proteins that interact with DNA and thereby to advance our ability to control genetic processes.